NATIONAL INSTITUTE OF HEALTH (NIH), NATIONAL CENTER FOR ADVANCING TRANSLATIONAL SCIENCE (NCATS), BESPOKE GENE THERAPY CONSORTIUM, COORDINATION CENTER, GENE THERAPY ASSET DEVELOPMENT AND PLATFORM OPERA

Program and Project Management Support for the coordination activities of the Bespoke Gene Therapy Consortium Coordination Center (BGTC CC) through the establishment of the BGTC CC Program Management Office (PMO), and to provide Subject Matter Expert (SME) and/or CRO resources and capabilities to fully constitute and perform the activities of the four (4) BGTC CC Cores. The four Cores and the PMO that constitute the BGTC Coordination Center, in close coordination with the NIH BGTC Program Director and Task Lead (TL), will lead the advisory, technical management, and related coordination activities of cross-functional clinical development project teams for the BGTC-sponsored Adeno-associated Virus Gene Therapy projects.
Rare diseases